Integrated Current Population Survey Data for Population Dynamics and Health Research

Project Summary/Abstract
This proposal seeks continued funding to expand and improve IPUMS CPS, an essential data resource for
research on population health and child well-being in the United States. IPUMS CPS streamlines access and
reduces technical barriers to analyzing data from the Current Population Survey (CPS), the nation's most
comprehensive source of data on the economic and social well-being of U.S. individuals and families, including
women of reproductive age and children. IPUMS CPS enables rigorous and reproducible research on population
dynamics and the social and economic contexts in which health inequities are created and reinforced, enabling
public policy based on sound scientific evidence.
Building on an impressive record of accomplishments since 2016, the project will undertake new initiatives to
ensure broad access, timely delivery, and innovative use of CPS data for population dynamics and population
health research. The project has five specific aims: (1) Database expansion to add more than eight million person
records by incorporating 65 new files that will be released between 2021 and 2026, including all CPS monthly
and supplement data; (2) Data and metadata improvement to enhance research opportunities, reproducibility,
and rigor; (3) Data access improvements to allow users to specify the combinations of CPS data they want
linked and the formats in which they will receive the data; (4) Data processing tool enhancement to reduce the
time to deliver new data to the research community and reduce the costs of maintaining the infrastructure over
the long run; (5) Expand and support the research community through targeted, thoughtful outreach, and active
user support and training.
CPS data are indispensable for analyzing demographic topics identified in the core mission of the NICHD
Population Dynamics Branch, including fertility, migration, population distribution, nuptiality, family demography,
population growth and decline, and the causes and consequences of demographic change. They also contain
rich measures of the most important non-clinical determinants of health and health inequities. The CPS is vital
for evaluating the consequences of social safety net policies for children, individuals, and families; the impact of
labor market disruption on marital transitions; and the implications of marital dissolution for economic well-being.
With data on entire households, analyses of individual-, couple-, family-, and household-level dynamics are
possible. Timely, user-friendly CPS data on the economic and social well-being of the U.S. population has never
been more urgently needed.

Public health relevance
Narrative IPUMS CPS is essential data infrastructure for research on population health and child and family well-being in the United States. IPUMS CPS streamlines access to the Current Population Survey (CPS)—the nation’s primary source of timely data on monthly labor force statistics and the economic and social well-being of its people—by harmonizing, documenting, linking, and freely disseminating CPS data through a powerful data access platform. IPUMS CPS dramatically reduces the cost and increases the rigor and reproducibility of the research on population dynamics and population health with transformative implications for public health.